Traffic-Related Ultrafine Particles Disrupt The Resolution Of Lung Inflammation

Abstract
It is now widely appreciated that uncontrolled inflammation is a unifying component in many widespread
diseases, including chronic lung disease. Inhalational exposure to respirable particulate matter can be an
important precipitant or exacerbant of lung inflammation. From our earlier results, the resolution of
inflammation is known today as an active process. There are several new families of specialized pro-resolving
mediators (SPMs) identified and characterized in acute inflammation. These protective mediators are
enzymatically produced and are agonists at specific receptors transducing cell type specific functional
responses critical in tissue resolution. Resolution programs of the inflammatory response are essentially
uncharted scientific terrain in environmental health and medicine. Fundamental information is critically needed
on the impact of environmental agents within the resolution response and whether they perturb resolution to
trigger chronic inflammatory responses and susceptibility to allergen induced asthma. Here, the laboratories of
Bruce Levy, Charles Serhan, Phil Demokritou, and Adam Haber collaborate and propose an innovative
proposal focusing on elucidating the impact of inhaled potentially hazardous traffic emitted ultrafine particles
(UFPs) on the new resolution programs that govern pro-resolving cellular and molecular mechanisms and
tissue catabasis in its return to homeostasis. Failed resolution or its disruption can lead to sustained lung
inflammation and enhanced susceptibility to allergen induced asthma.
This proposal will test an innovative hypothesis, namely that exposure to traffic-emitted UFPs disrupts
airway resolution mechanisms associated with allergic airway responses in part via changes in
specialized pro-resolving mediator production and action; and that delivering SPMs using a novel
nanocarrier platform can protect from UFP-initiated disruption of endogenous resolution mechanisms.
To test this hypothesis, an interdisciplinary team of scientists was assembled with expertise in environmental
health and particle health effect studies (Demokritou), computational biology (Haber), asthma, lung inflammation
and its resolution (Levy) and SPMs, SPM receptors and resolution (Serhan) to pursue the following specific aims:
Aim 1. Collect and physicochemically characterize traffic emitted UFPs in urban Boston,
Aim 2. Determine the impact of traffic emitted UFPs on the resolution of house dust mite (HDM) evoked allergic
airway responses, and
Aim 3. Determine the cellular and molecular mechanisms for UFP disrupted resolution of inflammation and
establish an SPM delivery system to activate catabasis.
These innovative and timely studies will establish the impact of environmental UFPs on endogenous resolution
programs in lung inflammation and lay the groundwork for new therapeutic approaches with resolution agonists
that promote active resolution of inflammation in our fight against environmental insults.

Public health relevance
Project Narrative Environmental exposure to traffic related air pollution is a risk factor for wheezing, asthma and other respiratory diseases and particulate matter can evoke specific immune responses that can adversely impact human health. In this proposal, we are determining if traffic emitted ultrafine particles disrupt natural pro-resolving mediators and resolution mechanisms for inflammation and lead to increased susceptibility for chronic inflammatory disease as well as increased susceptibility to allergen induced asthma.